Physiologic Stress and Epigenetic Mechanisms that Precipitate Risk for Suicidal Behavior in Nurses

PROJECT SUMMARY/ABSTRACT
The rate of suicide in nurses has reached alarming proportions, with recent estimates upward of 17.1 suicides
per 100,000 nurses each year—almost double that of the general population (8.6/100,000). Proposed is a
program of training and research using longitudinal design to investigate the associations among individual
(e.g., subjective mood, lifetime trauma) and work environment characteristics (e.g., shift type and duration); life
stressors (e.g., discrimination, lateral violence); and suicidal ideation or behavior in nurses. Whereas previous
research about suicide in nurses has been limited to postmortem data, cross-sectional studies or self-report
stress measures, the proposed project will collect longitudinal data and will use physiologic stress biomarkers
(hair cortisol) and epigenetics (DNA methylation) to better establish the temporal sequence of potential
nursing-specific risk factors (individual characteristics, life stressors, physiologic stress, and work environment
characteristics), and suicidal ideation or behavior in real-world clinical settings. Sleep will be tested as a
potential modifiable protective factor, as will nurse work environment characteristics (e.g., day vs. night shift).
Hair cortisol concentrations measure cumulative cortisol release and reflect past months of stress exposure,
thus avoiding diurnal variation effects and permitting the longitudinal investigation of real-world individual and
environmental exposures. Grounded in the Stress-Diathesis Model of Suicidal Behavior, we will recruit 100
nurses to undergo a series of psychological interviews (e.g., SCID-5-RV and Iowa Gambling Task),
quantitative survey measures using validated instruments, and hair cortisol concentrations every 3 months for
1 year. Further, we will explore genome-scale epigenetic mechanisms that potentiate harmful DNA methylation
on unique gene alleles, which exacerbate suicidal ideation or behavior and can potentially help us to better
understand genetic expression of stress adaptation in the search for biological mechanisms. We aim to identify
modifiable individual and work environment characteristics that could mitigate suicidal ideation or behavior,
even for those at high genetic risk. We will use a range of analytical strategies selected to test interactions and
moderating effects including latent growth curve modeling. The proposed research will be complemented by
experiential and didactic training, along with expert mentorship in the fields of (1) physiologic stress
measurement, (2) suicidology, (3) epigenetics/DNA methylation, (4) longitudinal analysis, and (5) professional
development and dissemination of findings. Results of this K08 application will yield data needed to inform final
variables and measures and a power analysis for a planned R01 submission in Year 5 that proposes a large-
scale longitudinal study in nurses. Overall, this K08 funding would support my path to research independence
and my overall goal of building evidence to better identify high-risk individuals for suicide and to inform the
development of individualized suicide prevention interventions in nurses and similar frontline workforce.

Public health relevance
PROJECT NARRATIVE The rate of nurses who die by suicide has reached alarming proportions, with some estimates higher than the general population and other similar workforces. However, there is limited evidence about individual and environmental factors that predispose a nurse to suicidal behavior in real-world clinical settings, nor are there significant investigations of the interplay between those factors and physiologic stress responses or epigenetics. This project will leverage advancements in stress measurement (hair cortisol) and epigenetic analysis (DNA methylation) to investigate which factors increase suicidal behavior in nurses, which may help to better identify high-risk individuals and to inform suicidal behavior prevention interventions.